Targeting cancer metastasis by inhibiting curvature-induced kinase activation

PROJECT SUMMARY/ABSTRACT:
The overwhelming majority of cancer-associated deaths are caused by cancer metastasis rather than primary
tumors. Cancer cells can metastasize, while normal cells cannot. This is due to unique characteristics that cancer
cells acquire as they progress and become more aggressive. Cancer cells undergo genetic mutations that allow
them to detach from the primary tumor, migrate through surrounding tissues, and enter the bloodstream or
lymphatic system. Detached cancer cells must resist anoikis - a form of programmed death that occurs when
cells detach from the extracellular matrix. In the absence of cell adhesions that provide survival signals for
anchored cells, metastatic cancer cells must acquire special traits that enable them to persist and survive during
invasion and in circulation. In this proposal, we aim to develop an effective therapy for solid tumors by targeting
a survival characteristic that is newly discovered and crucial for cancer cell survival during metastasis.
Very recently, we identified nanoscale membrane curvature as such a trait that is crucial for cancer cell survival
in suspension but not when cells are in contact with substrates. Membrane curvature is a physical property of
the lipid bilayer, but it is now recognized as an important and active constituent of biological processes. Curved
membranes create distinct microenvironments that facilitate or inhibit the recruitment of specific proteins involved
in signaling pathways. The discovery that the survival of cancer cells in suspension hinges on their nanoscale
membrane curvature, and that this curvature facilitates essential survival signals through curvature-induced
kinase activation, opens up new therapeutic avenues. In this proposal, we seek to unravel the molecular
mechanisms underlying curvature-induced kinase activation, to explore the function of curvature-induced kinase
activation in cancer metastasis, and to develop new therapeutic strategies by blocking curvature-induced kinase
activation. Through these studies, we hope to develop curvature-blocking approaches that selectively kill
metastatic cancer cells when they are detached from their surroundings without affecting normal cell survival
when they are anchored to the basement membrane and other cells. These studies could lead to new treatments
for combating metastatic cancer, addressing one of the most critical and challenging aspects of cancer therapy.

Public health relevance
PROJECT NARRATIVE: Cancer remains a leading cause of death worldwide and kills almost ten million people each year. This proposal aims to develop innovative therapeutic strategies by targeting a survival characteristic that is newly discovered and crucial for cancer cell survival during metastasis. Proposed studies have the potential to open up entirely new therapeutic avenues for solid tumors.